(R21) Physicochemical and toxicological assessment of the particulate matter (PM) from the Los Angeles Wildland-Urban Interface (WUI) Fires and its impact on respiratory health

EXECUTIVE SUMMARY/ABSTRACT
The increasing frequency and intensity of wildfires are having serious public health consequences.
Wildfire exposures have adverse health impacts, but the specific mechanistic effects remain unknown,
especially for wildland-urban-interface (WUI) fires. Due to the burning of human-made structures as well
as biomass in WUI fire episodes, the particulate matter with aerodynamic sizes less than 2.5 microns
(PM2.5) generated from WUI fires, (WFPM2.5), maybe more toxic than urban background PM2.5, which is
mostly generated from fossil fuel combustion, or pure biomass WFPM2.5. Such wildfire exposures will
have devastating health consequences, especially in those with existing disease such as asthma and COPD.
In January 2025, catastrophic WUI fires impacted Los Angeles(LA), resulting in a severe air
pollution event with high PM concentrations. During this event, in collaboration with UCLA, we deployed state-
of-the-art instruments in two locations to collect air quality data and size-fractionated WFPM for
physicochemical characterization and toxicological assessment. The WFPM samples are stored at 4°C, and
their physicochemical and toxicological properties must be analyzed in a timely manner to avoid degradation.
The proposed interdisciplinary project consists of two Aims and focuses on the impact of WFPM on
respiratory health. In Aim 1 we will perform detailed physicochemical analysis of the collected PM0.1 and PM0.1-
2.5 size fractions, including: i) X-Ray Fluorescence (XRF) for 28 trace elements; ii) Thermal Optical Carbon
(TOC) analysis of organic carbon (OC) and elemental carbon (EC) fractions; iii) GC-MS analysis of 105
polyaromatic hydrocarbons (PAHs); and iv) ICP-MS analysis of metal content;. In Aim 2 we will employ 1). a
translational ex vivo human precision-cut human lung slice (hPCLS) model and an in vitro primary cultured
HASM cell model to assess the effects of WFPM on airway function, including effects on
bronchoconstriction/dilation, excitation-contraction (E-C) coupling pathways, and secreted inflammatory
mediators; and 2). An in vitro THP-1 macrophage model to evaluate the effects of WFPM on the health and
innate immune function of alveolar macrophages, including multiple toxicity endpoints as well as phagocytosis
and killing of Acinetobacter baumannii, a prevalent cause of secondary bacterial pneumonia
The proposed time-sensitive work will provide a detailed physicochemical characterization of WUI
WFPM in LA in comparison to non-WUI WFPM and traffic-related PM, as well as its relative toxicity and effects
on respiratory health and will support the main hypothesis that WFPM from WUI fires is more toxic compared
to background PM. Findings and WFPM samples from this study are timely needed by public health risk
assessors and will also support future epidemiological and mechanistic studies on WUI fires and help
develop remediation strategies to protect the health of impacted communities.

Public health relevance
PROJECT NARRATIVE Wildfire smoke has serious adverse health effects, particularly among people with underlying respiratory diseases. In January of 2025, smoke from Los Angeles, CA wildland-urban-interface (WUI) fires created highly hazardous air conditions and burnt thousands of human-made structures. During this event, we gathered real- time air quality data and collected wildfire particulate matter (WFPM) for further physicochemical and toxicological analysis, which must be performed in a timely manner to avoid chemical degradation. We will perform a detailed physicochemical analysis of the WFPM and assess the effects of WFPM on respiratory and immune function. A human lung slice model and human airway smooth muscle cells will be used to assess the effects of WFPM on airway constriction, which could increase symptoms and morbidity in patients with asthma and COPD. A human lung macrophage model will also be used to assess the impacts of WFPM on the uptake and killing of bacteria, impairment of which could increase susceptibility to bacterial pneumonia. These studies will provide data needed by public health assessors and policymakers to evaluate and mitigate health effects.